EVALUATION OF BONE MINERAL DENSITY AND ATHEROSCLEROSIS IN SURVIVORS OF HSCT

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. This is a clinical protocol to determine the risk of decreased bone mineral density (BMD) and its association to atherosclerosis in long-term survivors of hematopoietic stem cell transplant (HSCT). This protocol will examine the potential risk factors for BMD loss in pediatric HSCT recipients.